Monitoring Health in Older Adults Using mHealth Technology: Framingham Offspring Study

Abstract
How to engage and retain older adults in longitudinal mHealth research is virtually unknown. This is of great
public health importance as many older adults have barriers to obtaining health care that technology may
overcome by permitting in-home monitoring of health including cognitive function. Using mHealth technologies
to obtain data more frequently and in real life settings, vs. research center examinations that occur years apart
presents a transformational opportunity for cohort studies and may lead to practical methods for monitoring risk
of Alzheimer’s disease and related disorders (ADRD). We previously developed an innovative, scalable digital
cardiovascular health monitoring system, the “electronic Framingham Heart Study” (eFHS)8 for use in middle-
aged adults, thus providing foundational experience that will support this proposal. We will extend eFHS to
enhance a smartphone app tailored for older participants. The app will capture patient-reported outcomes,
cognition, physical performance, social support, and health events (falls, hospitalizations). We plan to
investigate the usefulness of the mHealth system for monitoring health-related behaviors and we will relate the
digital data to brain aging including preclinical ADRD using in-person research grade neuropsychological (NP)
testing and brain MRI data. Specific Aims:
Aim 1. Enhance engagement strategies and identify factors associated with successful use of the
smartphone app and smartwatch among older adults at 3 months and 6 months. Successful use will be
defined based on adherence, including: 1) app-based completion of surveys and cognitive and performance
tasks (n=850); 2) wearing the smartwatch daily (n≈500). We will identify participant (e.g., age, sex, cognitive
status) and system-related factors (e.g., user-interface, navigation), that affect adherence over 3 and 6 months.
Aim 2. Compare the smartphone app-based data to research grade measures of brain health (NP
testing batteries, brain MRIs) collected in the FHS Research Center on the same participants. We will
compare the app-based measures with measures of brain health, including NP test measures (global cognition
and 4 domains: executive function, memory, language, visuospatial) and brain MRI markers (total brain
volume, hippocampal volume, white matter hyperintensity volume).
Sub Aim 2a: Construct a digital frailty phenotype.
Aim 3. Examine measures of physical activity and heart rate from the Apple Watch over 90 days with
research grade measures of brain health (see Aim 2).
Our application will provide critically needed knowledge on how older adults engage with mHealth devices
and will provide insights on the benefit of mHealth data to monitor the health of older adults in clinical and
research settings. Digital biomarkers may be powerful tools to monitor risk factors/behaviors for ADRD and to
identify older adults at risk for cognitive and physical decline.

Public health relevance
Project Narrative There is an urgent need to understand how to engage and retain older adults in use of mHealth technologies that permit in-home monitoring of health including cognitive function. In the community-based Framingham Heart Study, we propose to enhance engagement strategies and study factors associated with successful use of a smartphone application and smartwatch in older adults. We will investigate the usefulness of the digital data for monitoring risk factors for Alzheimer’s disease and we will relate the digital data to brain aging outcomes including preclinical Alzheimer’s disease using neuropsychological testing and brain MRI data.